Neural subtypes of developmental stuttering

Project Summary/Abstract
While the behavioral heterogeneity of stuttering has been long recognized, very little is known about
mechanisms underlying the heterogeneity. Without this knowledge, the complex etiology of stuttering cannot
be fully understood, and the development of individualized treatment approaches will continue to be severely
hindered. Our long-term goal is to develop neuroscience-based treatment approaches for developmental
stuttering. In pursuit of this goal, the objective of the present application is to identify subtypes of children who
stutter (CWS) based on neuroanatomical anomalies and characterize each subtype’s behavioral profiles and
brain activity during speech production. The central hypothesis is that each neural subtype is associated with
behavioral and brain activity changes consistent with its primary neuroanatomical anomalies. The rationale of
this proposed project is that elucidating the neural subtypes of stuttering will help us understand the
heterogeneity and neurological etiologies of the disorder, which is an important basis for developing new
treatment approaches that target individual neurological deficits. We will test our central hypothesis by
pursuing three specific aims. i) Identify subtypes of CWS based upon patterns of neuroanatomical anomalies.
To achieve this aim, we will use a clustering method to analyze gray matter volume patterns in CWS. We
hypothesize that CWS comprise neural subtypes, characterized by primary structural anomalies in the
prefrontal areas, the basal ganglia thalamocortical circuit and the cerebellum. ii) Characterize behavioral
profiles associated with each neural subtype. Based on contemporary models of speech motor control, we
hypothesize that each neural subtype will differ in both stuttering behaviors, language ability, and speech motor
performance depending on the functions of its primary neuroanatomical anomaly loci. iii) Characterize brain
activity associated with speech production in each neural subtype. To achieve this aim, we will identify
differences in brain activity between neural subtypes during overt continuous speech using functional magnetic
resonance imaging. Our working hypothesis is that compared to controls, each neural subtype of CWS will
exhibit reduced activation associated with its primary anatomical anomalies as well as their common input
region, the left premotor areas. Upon successful completion of the proposed research, we expect to gain an
expanded understanding of anatomical neural subtypes of stuttering, and for the first time, link behaviors and
brain activity differences during speech production among the different subtypes. Better characterizing neural
subtypes of stuttering would substantially contribute to our understanding of the heterogeneity of stuttering,
which is an important step in elucidating the disorder’s complex etiology.

Public health relevance
Project Narrative The proposed research is relevant to public health because advancing our understanding of the neuroanatomical, neurophysiological and behavioral heterogeneity in developmental stuttering is expected to elucidate the disorder’s complex etiology and form the foundation for developing customized treatment approaches to target individual neurological and behavioral deficits associated with stuttering. Thus, the proposed research is relevant to NIDCD’s mission that pertains to improving the lives of people with communication disorders.